DP21-001 Component 1: North Dakota Pregnancy Risk Assessment Monitoring System (ND PRAMS)

7. Project Summary/Abstract
The North Dakota Department of Health (NDDoH) is applying to implement a statewide
Component A: Core Surveillance Pregnancy Risk Assessment Monitoring System
(PRAMS) program in order to collect maternal and early infancy data critical to maternal
and child Health programmatic planning, currently not available in North Dakota. The
specific aims of this research include: 1) to utilize the Centers for Disease Control and
Prevention (CDC) model protocol to effectively collect, analyze and disseminate timely
and highly-scientific quality data on maternal risk factors, behaviors and attitudes
relating to pregnancy and early infancy that will result in translational efforts that reduce
adverse maternal and infant outcomes; and 2) to foster partnerships and culturally
competent data collection, analyses, and dissemination practices within ND
communities, including American Indian communities, in an effort to adequately monitor
modifiable risk factors and minimize disparities. Using the standardized protocol from
CDC, the ND PRAMS Program will implement the data collection, analyses and
dissemination aspects of PRAMS research. ND PRAMS will oversample the ND
American Indian maternal population. Analyses and dissemination of data will be
conducted on a regular basis through fact sheets, data reports, etc. The ND PRAMS
program will also work to modify the PRAMS protocol, as necessary, to ensure
adequate data collection of emerging needs such as population changes, epidemics,
environmental issues, etc. The ND PRAMS Program led by the Program
Director/Principal Investigator, along with its advisory group/Steering Committee, will
ensure adherence to the CDC standard protocol; develop culturally competent
educational materials and a stipend plan to encourage participation; and develop a data
dissemination and translation plan. The ND PRAMS Steering Committee will also
include a tribal subcommittee that will provide leadership for PRAMS data collection,
analysis and dissemination efforts for tribal communities. Data collected through
PRAMS will complement other local and national data sources and allow for comparison
with other states on maternal characteristics and subsequent early infancy outcomes.

Public health relevance
RESEARCH AND RELATED Other Project Information 8. Project Narrative The North Dakota Department of Health (NDDoH) is applying to implement the Component A: Core Surveillance Pregnancy Risk Assessment Monitoring System (PRAMS). The purpose of PRAMS in the state will be to initiate and enhance surveillance on maternal and early infancy risk factors in order to translate data into relevant public health interventions that will improve the health of mothers and infants in North Dakota.